Cardiopulmonary effects induced by electronic-cigarette and JUUL aerosols in both in vivo and in vitro models.

PROJECT SUMMARY/ABSTRACT
Candidate background: I received my PhD from the University of Montreal (Canada) with a dissertation on
pulmonary responses induced by inhaled TiO2 nanoparticles. This research provided me with a solid expertise
in lung biology and inhalation toxicology. During my post-doctorate at Louisiana State University (LSU) under
the supervision of Dr. Arthur Penn, I received high quality training in tobacco science, including on second-hand
smoke and electronic-cigarettes (e-cigs). I am currently an Assistant Professor at LSU, with a research program
that focuses on electronic nicotine delivery systems (ENDS) and their pulmonary health effects.
Career goals and objectives: My long-term career goals are to become a well-funded independent scientist in
the fields of tobacco regulatory science, as well as to attain a tenured Professorship in a research-intensive
academic institution. My research goals are to enhance our understanding of the impact of e-cig and JUUL
aerosol exposures on lung development and on cardiopulmonary responses. This mentored award will support
my career goals by providing protected time to learn new techniques and expertise from my mentoring team.
Career development and training activities: I plan to use this mentored award to gain expertise in lung
immunology and cardiovascular effects caused by exposures to tobacco-related products to complement my
expertise in tobacco-related pulmonary effects. This will be supported by my mentoring team. Dr. Stephania
Cormier will be my primary mentor in flow cytometry and lung immunity. Dr. Kent Pinkerton’s mentoring will allow
me to expand from solely pulmonary assessment to cardiovascular evaluations of effects induced by ENDS. Dr.
Tammy Dugas will be my primary mentor in assessing vascular function in mouse models following exposures
to ENDS aerosols. I will also complete a bioinformatics course, attend seminars and present at conferences.
Research strategy – Summary: The prevalence of ENDS use in the US is 8 million adults, of whom 70% are
dual-users of classic cigarettes and e-cigs. Little is known regarding the cardiopulmonary effects due to chronic
inhalation of ENDS aerosols. Clinical evidence demonstrates declines in lung function and increases in risks of
myocardial infarction in healthy dual-users. Since biomarkers of harm with predictive value for cardiopulmonary
diseases in dual-users exist, we hypothesize that these biomarkers can serve as a basis for the evaluation of
cardiopulmonary toxicity related to long-term inhalation exposures to e-cig or JUUL in single-users. We will study
how two ENDS products of different design -- 1) open system e-cig devices, and 2) closed system JUUL devices
-- impact individual or combinations of the constituents found in these aerosols, and their toxicity. Our goals are
A) to examine the roles that e-liquid constituents play in the chemical profile and in vitro toxicity of ENDS
aerosols; and B) to define a panel of biomarkers for cardiopulmonary effects following exposures to either dual-
use of cigarettes and e-cigs, or sole exposures to e-cig or JUUL aerosols using in vivo models. Thus, this study
has a high societal impact since it will help inform the regulatory agencies and the 8 million adults ENDS users.

Public health relevance
PROJECT NARRATIVE Electronic nicotine delivery systems (ENDS), including electronic-cigarettes and JUUL devices, have become increasingly popular among smoking and non-smoking pre-teens, teenagers and adults. Little, however, is known about the long-term cardiopulmonary effects of ENDS aerosols. We will use ENDS exposure systems we have developed, combined with biomarkers of toxicity and physiological changes found in dual-users (cigarette plus ENDS), to predict early signs of cardiopulmonary toxicity induced by sole exposures to ENDS aerosols.